ANTICANCER AGENTS FROM UNIQUE NATURAL PRODUCTS SOURCES

[unreadable] DESCRIPTION (provided by applicant) 4 [unreadable] [unreadable] COLLABORATING INSTITUTION (S) 4 [unreadable] [unreadable] [unreadable]